Xenopus Mutant Resource

Project Summary
The Xenopus Mutant Resource (XMR) was created in 2020 as an R24 resource center at the National
Xenopus Resource (NXR) at the Marine Biological Laboratory in Woods Hole, MA. The purpose of the XMR is
to create new mutant and transgenic lines in both Xenopus laevis and Xenopus tropicalis and to provide a
destination for researchers to come and work on these various lines. An essential component of the XMR is
the ability to host visiting scientists. This grant supports a project to purchase additional equipment that will
allow us to more efficiently genotype our animals and be able to quantitatively examine gene expression
changes.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research including cell biology, development, neurobiology, physiology and signal transduction. This proposal seeks to generate and characterize different Xenopus mutants in key genes related to human diseases using new technology, which will help provide significant insights about the causes of these diseases.